Local and Sustained Release of Antibiotics in the Surgical Treatment of Diabetic Charcot Foot

Charcot Osteoarthropathy (COA), a severe complication of diabetes mellitus, often leads to destructive bone
and joint degeneration, significant deformity, and increased risk of amputation. Surgical interventions for COA
and other hindlimb arthropathies are frequently complicated by infections such as osteomyelitis. Chronic
osteomyelitis is challenging to treat because antibiotic-tolerant bacteria often persist, resulting in frequent
infection recurrence, extended recovery periods, and higher healthcare costs. This project seeks to address
these challenges by developing the Reselution™ Hindfoot Intramedullary Nail (ReselutionTM HFN). This
combination product integrates robust structural support with sustained local antibiotic delivery to prevent
infections while stabilizing fractures and fusions. The long-term goal of this research is to improve outcomes for
diabetic patients suffering from orthopedic infections and reduce the morbidity associated with COA-related
complications. The goals of this project are to (1) develop a prototype of a shelf-stable prefabricated antibiotic-
loaded nail (2) develop a manufacturing process for the Reselution HFN (3) complete preclinical verification
testing to ensure performance standards are met, and (4) verify the device’s safety and efficacy in a large animal
model. The project employs a rigorous pre-clinical research and development strategy in preparation for
regulatory submission. In vitro studies will evaluate the shelf life, release kinetics, and antimicrobial efficacy of
the antibiotic core, while mechanical testing will ensure the implant meets load-bearing requirements for hindfoot
fusion. An established ovine model of hindlimb fusion will be used to validate the device’s radiographic outcomes
and histological safety. The Reselution HFN has the potential to redefine the standard of care for high-risk
patients with hindlimb arthropathies, such as COA, by combining structural stability with sustained local antibiotic
delivery to reduce infection and amputation rates. By enabling faster recoveries, preserving mobility, and
lowering the social and economic burden of diabetes-related complications, this innovation supports improved
clinical outcomes and enhanced patient quality of life, addressing a critical need in a high-risk population.

Public health relevance
Charcot Osteoarthropathy (COA), a debilitating complication of diabetes, often requires surgical fusion of the hindfoot to restore stability and prevent progression to severe deformity, ulceration, and amputation. The Reselution™ Hindfoot Intramedullary Nail aims to improve outcomes for patients with COA by combining mechanical stability with localized, sustained antibiotic delivery to reduce the risk of infection—a common and devastating complication in this population. By addressing both structural and infection control needs, this research directly supports efforts to reduce disability, improve quality of life, and mitigate the healthcare burden associated with diabetes-related complications.